Bioinformatics Biostatistics Core

The purpose of the Bioinformatics and statistics core is to provide bioinformatic and statistical support
for clinical, genomic and laboratory studies. A wide variety of studies are supported by the core and
the core resources have been extensively used by our research community. In response to this high
demand in this competing renewal we have added additional personnel to the core and have focused
activities on those that are most requested by MEE investigators. The core resources are targeted to
MEE investigators with qualifying R01s but are also used by other investigators and have been
especially valuable for young investigators who are starting new research projects who would
otherwise not have access to these resources. The Bioinformatics and statistics core resources and
expert personnel provide opportunities for collaboration and stimulate new research ideas and
investigations. By helping investigators plan effective investigations and efficiently and appropriately
analyze experimental data, the Bioinformatics and statistics core has enhanced the quality of vision
research at MEE and has promoted increased productivity of the vision science program. Similar to
the other cores for this P30 Core grant, the resources provided by this core broadly impact the
translation of basic science discoveries to improve our understanding of the pathogenic features of
clinical disease and to develop new therapies and diagnostic modalities. In particular, the availability
of the core resources draws clinical investigators into research studies, thus enhancing the translation
of research discoveries.